MOOD/ANXIETY DISORDERS INITIATIVE-RAT/MOUSE MODELS OF DEPRESSION AND ANXIETY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. During the reporting period, we have begun to evaluate how serotonin reuptake inhibitors and GSK compounds will affect our measures of fear vs. anxiety and whether over expression of CRF in CRF neurons in the amygdala will provide a novel model of anxiety.